Yale SPORE in Skin Cancer

OVERALL: PROJECT SUMMARY
The Yale SPORE in Skin Cancer (YSPORE), now in its third funding cycle, involves a broad range of projects
and investigators with diverse expertise, whose goal is to decrease mortality from melanoma by developing novel
drugs and regimens to treat patients once it metastasizes and develop predictive biomarkers to select patients
for the optimal treatment regimen. YSPORE leans on the immense scientific and clinical strengths at Yale School
of Medicine and Yale Cancer Center including immunobiology, genetics, epigenetics, quantitative sciences,
immuno-oncology, animal models, and digital pathology. YSPORE investigators have made major contributions
in recent years to developing improved immune therapy approaches for melanoma patients with advanced
disease and novel single cell tumor profiling platforms. Advances in systemic therapies for advanced melanoma,
particularly immune checkpoint inhibitors, that prolong survival, pose a new set of challenges for clinicians which
will be addressed by the proposed research program, as we strive to increase the long term survival for all
melanoma patients. The YSPORE translational research team proposes to accomplish the objective of
decreasing morbidity and mortality from skin cancer through four specific aims: Specific Aim 1: Develop new
approaches to enhancing activity of PD-1 inhibitors by co-targeting the innate and adaptive immune systems in
immune checkpoint inhibitor naïve patients; Specific Aim 2: Study novel drugs that target the epigenetic modifier
KDM5B, to upregulate endogenous retroelements and enhance T cell infiltration in tumors that are unresponsive
or poorly responsive to immune checkpoint inhibitors; Specific Aim 3: Study novel cytokines to overcome
resistance to immune checkpoint inhibitors in patients whose melanoma has progressed on anti-PD-1; and
Specific Aim 4: Develop new research directions to decrease mortality from melanoma and nurture the next
generation of translational investigators focusing on skin cancer through a Developmental Research Program
and a Career Enhancement Program. We propose three cores (Administrative Core, Biospecimen Core and
Biostatistics and Bioinformatics Core) to support the projects, their clinical aims, mechanistic studies, and
biomarker development for clinical application. The Projects and Cores are designed to be highly coordinated
with the goal of maximizing resources and potential impact. New collaborations will be established during the
funding period through the Developmental Research Program with the support of the Administrative Core.
Collaborations with other institutions and skin cancer SPORE sites will be fostered by the Administrative Core.
These coordinated efforts will enhance analysis of patient samples, use of cell cultures and animal models, and
development of predictive biomarker assays. Our purpose is to translate the innovative approaches proposed
here to clinical therapies for treatment of advanced skin cancer.

Public health relevance
OVERALL: PROJECT NARRATIVE The goal of the Yale SPORE in Skin Cancer is to decrease morbidity and mortality from melanoma. We have assembled a group of interdisciplinary investigators to conduct a series of bench-to-bedside studies aimed at preventing melanoma and improving outcomes for patients in whom melanoma has metastasized. These studies will capitalize on advances made in the last funding period and build on the extensive resources, such as tumor samples, animal models, and novel drugs and technologies, developed in the past decade by YSPORE investigators.